Medicaid Medical Director Network Workshop

ABSTRACT - The Fall Workshop of the Medicaid Medical Directors Network (MMDN) provides an
opportunity for members to connect in-person to develop strong networks and create lasting trusted
connections. The in-person meeting facilitates interactions between Network members, but also to
connect the membership with federal policymakers, funders, and other subject matter experts or key
partners, as appropriate. While the exact agenda will be determined in concert with the Steering
Committee, the design of each meeting balances informative presentations, peer-to-peer interaction
and problem-solving, and structured and unstructured networking. We anticipate holding the in-person
workshops in the fall of each year (2021-2023). The Medicaid Medical Directors Network (MMDN) is a
vibrant learning community of senior clinical leaders of state Medicaid programs, who are dedicated to
advancing the health of Medicaid beneficiaries. It’s original iteration, the Medicaid Medical Directors
Learning Network, was established in 2005 under AcademyHealth’s previous Knowledge Transfer and
Implementation contract with the Agency for Healthcare Research and Quality’s Office of
Communications and Knowledge Transfer. The MMDN provides a forum for these clinical leaders to
discuss their most pressing needs and share best practices, focusing on the development and use of
evidence-based medicine, measurement and improvement of health care quality, and the redesign of
health care delivery systems. AcademyHealth facilitates the MMDN to assist clinical leaders in
identifying and applying the latest research findings to address high priority policy and program issues,
especially related to quality assurance, quality improvement, and coverage decisions. Conference
sessions present research that can improve policy and practice, patient safety and quality, patient
centered care, and payment and organization. Because of the Network’s focus on Medicaid, the
workshops also center on AHRQ’s priority populations—low income groups, minority groups, women,
children, the elderly, individuals with disabilities and end-of-life care.

Public health relevance
NARRATIVE AcademyHealth seeks a Small Conference Grant to foster peer-learning and engagement for the Medicaid Medical Directors Network to discuss their most pressing needs and share best practices, focusing on the development and use of evidence-based medicine, measurement and improvement of health care quality, and the redesign of health care delivery systems. With this conference, AHRQ has an opportunity to help fill existing research gaps and assess the comparative effectiveness of competing approaches to delivery system improvement. By providing support for the MMDN Fall Workshop, AHRQ gains an important resource to both inform and implement AHRQ priorities and programs.